MGHfC Digestive Disease Summer Research Program

PROJECT SUMMARY / ABSTRACT
In 2015, Massachusetts General Hospital for Children (MGHfC) established the MGHfC Digestive Disease
Summer Research Program with the objective of providing short-term support for 10 undergraduate and/or
medical students to conduct mentor-supervised independent research in the setting of a research-oriented
teaching hospital. Students perform an independent research project focused on digestive diseases on a full-
time basis over a ten-week period during the summer months within a laboratory or collaborating laboratory of
MGHfC faculty. Collaborating laboratories of the MGHfC are laboratories within the Massachusetts General
Hospital (MGH) community that possess unique expertise in engineering and computational sciences currently
being leveraged to support various projects centered on digestive disease research. In addition to conducting
an independent project to be formally presented at a summer's end symposium, each student participates in a
peer-driven biomedical course entitled “Immunity, Microbes, & the Mucosa” as well as a panel discussion on
careers in biomedicine facilitated by faculty and biomedical professionals. Currently 22 MGH independent
investigators with interest in digestive diseases serve as mentors and have hosted students in their
laboratories since 2015. An advisory board that includes the program director, associate director, and a faculty
member is responsible for overseeing the program as well as recruiting and selecting participating students
each summer. The MGHfC Digestive Disease Summer Program has recruited approximately fifty students
from regions throughout the United States since its inception and this proposal seeks funding to support the
continuation of this program with the objective of recruiting and training at least fifty additional students over
the next five years. Several former students are of backgrounds under-represented in biomedical science
careers and strategies are in place to continue to recruit this vital cohort of future researchers into the field of
digestive diseases. Our goal is to continue to immerse undergraduates and medical students in a structured
and intensive research experience that will serve to encourage them to continually seek opportunities to
develop their scientific and research skills as they move forward in their careers and inspire them to ultimately
become part of and thereby reinforce the biomedical research workforce.

Public health relevance
PROJECT NARRATIVE Massachusetts General Hospital for Children (MGHfC) Digestive Disease Summer Research Program is an NIH-NIDDK-funded educational program that was established in 2015 to engage early-career students in projects that explore various aspects of digestive disease and encourage these students to consider a career in the biomedical sciences. Undergraduate and medical students participate in a 10-week didactic program each summer that includes mentored supervision of independent research, faculty lectures, peer-to-peer scientific presentation / discussion, and career development activities. Providing an independent mentor- supervised research experience for students at an early stage is known to be effective at fostering a strong interest and appreciation for biomedical research and significantly increases the likelihood that a student will pursue future research opportunities and eventually enter the biomedical research workforce.